Actin Assembly and Clathrin-mediated Endocytosis in Yeast and Mammals

PROJECT SUMMARY/ABSTRACT N/A - No changes from Parent Award.

Public health relevance
PROJECT NARRATIVE N/A - No changes from Parent Award.